Sex-dependent shifts in behavioral profiles and cortical signaling following adolescent binge drinking

PROJECT SUMMARY / ABSTRACT
Along with the structural development of the prefrontal cortex (PFC) during adolescence, innervation of the PFC
by several local neurotransmitter systems also develops, including the gamma-aminobutyric acid (GABA)
system. Somatostatin (SST)-expressing GABA cells undergo significant developmental changes throughout
adolescence, including in structure and function (Du et al., 2018) – importantly, SST neurons are a cell
population known to be vulnerable to alcohol in adulthood (Dao et al., 2020, Dao et al. 2021). However, little is
known about how developmental alcohol exposure may influence this key GABAergic and peptidergic
population in the PFC – which could, in turn, lead to catastrophic, irreversible changes in PFC signaling and
functional connectivity. Additionally, sex differences in the development of the PFC SST system may render it
uniquely vulnerable to adolescent alcohol consumption.
The objectives of this application are to characterize changes in behavior, overall cortical adaptations in SST
neuron function and peptide signaling, and functional connectivity following developmentally relevant periods
of adolescent binge alcohol consumption. Using the drinking-in-the-dark (DID) model of voluntary binge alcohol
consumption, we will assess how adolescent-specific exposure to alcohol alters sex-specific long-term behavioral
phenotypes, somatostatin peptidergic circuits, and overall brain systems, thereby linking a localized cell-
type specific change with behavior and brain dynamics on a network scale. Using complementary
approaches, we will systematically and comprehensively test the hypothesis that adolescent alcohol changes
behavioral profiles, SST neuron and peptide function, and functional connectivity of the PFC. We will use a
multidisciplinary approach spanning slice electrophysiology, in vivo signaling, quantification of cycling sex
hormones, and resting-state functional connectivity to systematically characterize this system. Additionally, we
will identify risk factors for later alcohol-induced behavioral changes using non-invasive imaging throughout
drinking.
These high-impact experiments have significant public health implications. By understanding the role of an
understudied population of cortical peptidergic neurons, new treatment targets may be informed. Additionally,
the rapid timescale of animal developmental models allows for a faster and more in-depth characterization of
the effects of adolescent binge drinking compared to human studies, which span decades. This work is likely to
significantly inform prevention and intervention efforts related to adolescent binge drinking.

Public health relevance
PROJECT NARRATIVE Adolescent alcohol exposure has profound effects on brain development and adulthood substance misuse, but the neuroadaptations that drive sex-dependent susceptibility and resiliency in response to adolescent drinking remain unknown. Our project aims to address this gap by using advanced technologies and well-founded methods to launch a hypothesis-driven investigation into the involvement of a specific population of neurons (SST neurons), their interactions with sex hormones, and how this system is altered at multiple time points post- adolescent alcohol exposure. This work will provide key insights into the neurobiological underpinnings of adolescent binge drinking—a major public health problem and precursor to adulthood alcohol use disorder (AUD).